Training Program in Substance Use Disorders

SUMMARY
The Training Program in Substance Use Disorders at the Icahn School of Medicine at Mount Sinai (ISMMS)
will offer late-stage predoctoral (PhD) students and early-stage postdoctoral fellows an integrated program of
training in substance use disorders (SUDs) research that leverages the exceptional expertise in cellular,
molecular and behavioral neuroscience, translational neuroscience, neurology, psychiatry, genomic science
and pharmacological sciences at ISMMS. The overarching goal of the program is to provide rigorous, broad-
based, individualized, and multidisciplinary training with enhanced opportunities for mentoring, collaboration,
and career development designed to prepare the next generation of independent investigators in SUDs
research. At the heart of this new Training Program will be a superb training faculty representing remarkable
diversity in basic and clinically relevant topics; from synaptic plasticity and chromatin remodeling; cognitive,
social, and emotional disorders; disorders of mood, motivation, and anxiety; addiction; human
neuropsychology; and cognitive neuroscience – all relevant to SUDs. The Training Program comprises inter-
related components: academic coursework, laboratory training, non-curricular training activities (seminars,
retreats, etc.), testing/evaluation, teaching opportunities, mentoring, and career development activities. The
diverse research environment at ISMMS will provide for laboratory opportunities in core areas of strength,
including in translational neuroscience, computational neuroscience, neuropsychiatric genomics,
neuroimaging, epigenetics, and synaptic and behavioral plasticity, and the study of diverse model systems.
The Training Program includes more than a dozen initiatives that have been newly created or adapted from
existing programs to support training in SUDs, which emphasize multidisciplinary collaborations, and the
promotion of exceptional rigor and creativity. Pre- and post-doctoral trainees will participate in required and
optional training activities to ensure strong grounding in basic neuroscience and opportunities to learn from and
with peers and faculty from across ISMMS, including those in the Graduate School of Biomedical Sciences, the
medical school, interdisciplinary Centers and Institutes, and the Friedman Brain Institute. Creating a structured
culture of mentoring across the career continuum of participants is a hallmark feature of the Training Program.
Formal and informal advising and mentoring will be integrated into training across roles and levels, including
mentoring opportunities for training faculty and sponsors (preceptors). Integrating predoctoral and postdoctoral
training through formal mechanisms will provide greater continuity in the overall training experience, enhanced
opportunities for collaboration among trainees interested in pursuing careers in SUDs research, and will benefit
the neuroscience research effort at ISMMS. The Training Program in Substance Use Disorders will prepare the
most promising trainees for productive, independent careers in SUD research at all levels – from preclinical
genetics, cellular and molecular mechanisms of the disorders, to clinical research and interventions.

Public health relevance
PROJECT NARRATIVE The Training Program in Substance Use Disorders provides rigorous training in basic and translational research in substance use disorders for late-stage predoctoral and early-stage postdoctoral trainees through an integrated program of coursework, mentoring, training activities, teaching opportunities, and career development to prepare talented trainees for independent research careers in substance use disorders at all levels – from preclinical genetics, cellular and molecular mechanisms of the disorders, to clinical research and interventions.